Neural Computations Underlying Cancellation of the Vestibular Consequences of Voluntary Movement

Project Summary: This research program is motivated by three goals. First, we will establish the cerebellar
mechanisms that underlie the brain's ability to estimate and cancel self-generated vestibular (inner ear balance)
input during active movement Second, we will determine how the cerebellum encodes changes in the
relationship between expected and actual sensory input when these predictions are learned, adapted, and
flexibly implemented. Third, we will assess how cerebellum-mediated vestibular reafference suppression
generalizes to another natural self-motion behavior, namely standing balance and its adaptation.
The brain's ability to distinguish sensory stimuli that are the result of self-generated (Le., active) versus
unexpected or externally generated (i.e., passive) stimulation is vital to ensuring perceptual stability and accurate
motor control. Notably, in the vestibular system, the same central neurons that receive afferent input also send
direct projections to motor centers to control posture via vestibular-spinal reflexes. These are essential for
providing robust postural responses to unexpected vestibular stimuli yet counter-productive when the goal is to
make active head movements. Accordingly, it is advantageous to suppress this pathway during active self-motion.
Over the past two decades, we have made excellent progress toward identifying how the brain makes the
distinction between active and passive vestibular signals - vestibular reafference vs. exafference, respectively.
While vestibular afferents responses remain robust (and equivalent) regardless of whether stimulation is active
or passive, neural responses at the next stage of processing in the vestibular nuclei are significantly attenuated
during active stimulation. Further, this selective suppression of vestibular reafference only occurs when sensory
feedback matches that expected based on motor command (e.g., during active movements). During the current
grant period, we established that the cerebellum integrates sensory and motor inputs to make the required
distinction between reafference and exafference. In the proposed research, we will address several fundamental
questions that remain open. First, Aim 1 will establish how the cerebellum learns to interpret active motion as
self-generated when the relationship between the actual and expected sensory feedback is altered. Aim 2 will
determine how the vestibular cerebellum computes the expected consequences of self-motion when predictions
must adapt to changes in the statistics of sensory feedback and/or be flexibly implemented across contexts.
Finally, in Aim 3 we will determine whether and how cerebellum-mediated vestibular reafference suppression
generalizes to another natural self-motion behavior: standing balance and its adaptation to perturbations.
Combined, these studies will (1) advance our understanding of how the cerebellum computes the expected
consequences of self-motion in everyday life when predictions are learned, adapted, and flexibly implemented,
and (2) establish how the mechanisms underlying reafference suppression ensure postural stability.

Public health relevance
Narrative The loss of vestibular (self-motion) sensation due to disease or aging can produce gaze instability, dizziness, imbalance, and an increased risk of falls – all symptoms that profoundly impair quality of life. This research project will identify the fundamental mechanisms underlying the vestibular system's ability to create neural representations of our self-motion during everyday activities to ensure the maintenance of balance and posture, as well as accurate perceptual stability. In turn, this knowledge will positively impact the lives of patients suffering from vestibular disorders through the development of improved diagnosis and treatment.